Regulation of Type 1 Interferon Production by Autoimmunity-Associated PTPN22

DESCRIPTION (provided by applicant): Autoimmune diseases in aggregate represent a leading cause of morbidity and mortality. Despite apparent clinical heterogeneity among human autoimmune diseases, the potential for shared pathogenetic mechanisms involving inflammatory cascades, is increasingly appreciated. Dysregulation of biochemical pathways leading to production of type 1 interferon (T1 IFN) represents a candidate shared mechanism of enhanced susceptibility to diverse syndromes including systemic lupus erythematosus (SLE), rheumatoid arthritis (RA), and Type I diabetes (T1D). Genome-wide association studies have identified a number of genetic polymorphisms that convey an increased risk for autoimmune diseases through largely unknown mechanisms. One such genetic variant is the PTPN22 C1858T, which leads to an Arginine to Tryptophan (R->W) change in the Lymphoid tryrosine phosphatase (Lyp). This variant is associated with increased risk for SLE, RA, T1D, and autoimmune thyroiditis. Expression surveys reveal that PTPN22 is highly expressed in the myeloid cells implicated in host defense responses involving T1 IFN. Other phosphatases, such as PTPN11 and SHIP-1 have been shown to regulate innate immune responses in myeloid cells through Toll-like receptor (TLR) signaling pathways. TLRs recognize components derived from microbial pathogens and play a central role in innate immunity. However, abnormal TLR activation can modulate human immunodeficiency or autoimmunity. My overall hypothesis is that abnormal innate and adaptive immune responses resulting from the disease-associate Lyp (LypW) variant contribute to pathogenesis of autoimmune diseases. I plan to address this hypothesis through completion of specific Aims designed to not only contribute significantly to the biology of PTPN22, but also provide me with training essential for successful transition to independence. In Aim 1, I will determine the role of PTPN22 in TLR signaling by using bone-marrow derived macrophages (BMMs) and dendritic cells (BMDCs) from PTPN22 deficient mice. I will compare gene expression and transcription factor activation as well as IFN-dependent phosphorylation of STAT1 and upregulation of costimulatory molecules in wild-type and PTPN22 deficient cells after TLR activation. I will also determine the role of PTPN22 in controlling antigen-specific T cell proliferation and activation. I will identify PTPN22 containing protein complexes involved in TLR signaling by Mass Spectrometry. In Aim 2, I will address the impact of LypW on TLR signaling by using BMMs and BMDCs from LypW transgenic mice. I will also investigate the role of LypW in pathogenesis of rheumatoid arthritis using the K/BxN TCR transgenic mouse model. In Aim 3, I will compare gene expression and surface phenotype after TLR activation in human peripheral mononuclear cells from LypW carriers and non-carriers. I will determine the role of LypW in host immune responses to viruses.

Public health relevance
PUBLIC HEALTH RELEVANCE: Autoimmune diseases are complex polygenic diseases. Identifying the functional significance of the genetic variants associated with these diseases will provide insight into novel therapeutic targets and treatment for these diseases. In this grant I wil study the function of a genetic variant associated with multiple autoimmune diseases, the PTPN22 1858T variant, to examine its role in immune responses and disease pathogenesis. Autoimmune diseases are complex polygenic diseases. Identifying the functional significance of the genetic variants associated with these diseases will provide insight into novel therapeutic targets and treatment for these diseases. In this grant I wil study the function of a genetic variant associated with multiple autoimmune diseases, the PTPN22 1858T variant, to examine its role in immune responses and disease pathogenesis. __SpecificAimsTextDelimiter__ Specific Aims The long term goal of this research proposal is to determine the mechanisms by which PTPN22 C1858T variant contributes to autoimmune disease susceptibility. Protein tyrosine phosphatase nonreceptor type 22 (PTPN22) encodes Lymphoid tyrosine phosphatase (Lyp) in human and PEST-domain-enriched protein tyrosine phosphatase (Pep) in mouse. Lyp and Pep belong to the protein tyrosine phosphatase (PTP) family, which are important regulators of many cellular functions and have been implicated in human diseases38. Since 2004, a single nucleotide polymorphism in PTPN22 has been reported as an autoimmune susceptibility locus that associates with multiple autoimmune diseases including rheumatoid arthritis (RA)1,2. This PTPN22 C1858T variant leads to an Arginine to Tryptophan (R->W) change in Lyp39. However, the mechanism by which the disease-associate Lyp variant (LypW) conveys an increased risk for autoimmune diseases is largely unknown. Recent reports reveal that PTPN22 is highly expressed in the myeloid cells implicated in host defense and innate immunity4. Despite the extensive research on the function of PTPN22 in T and B lymphocytes, we know little about the role of PTPN22 in non-lymphocytes including myeloid cells. Our preliminary data indicate an unexpected requirement for Ptpn22 in Type 1 interferons (T1 IFNs) production in macrophages after Toll-like receptor (TLR) activation. Furthermore, we expect to see a "gain-of-function" of LypW in TLR signaling to induce overproduction of T1 IFNs. Hence we hypothesize that abnormal innate and adaptive immune responses resulting from LypW contribute to the pathogenesis of autoimmune diseases including rheumatoid arthritis. The successful completion of our goals would lay the biological foundation for discovering drugs that may block autoimmune responses in RA and other autoimmune diseases, especially in genetically predisposed individuals. We plan to address our hypothesis through completion of three Specific Aims. Specific Aim #1: Determine the role of Ptpn22 in TLR signaling In macrophages, TLR4 and TLR3 activate T1 IFN production through a TRIF-dependent signaling cascade involving TRAF3, TBK1/IKKi, and the transcription factor IRF310. T1 IFN leads to activation of the JAK/STAT pathway and has been shown to play critical roles in maturation of antigen presenting cells by up-regulating expression of costimulatory molecules15. Based on our preliminary data, we hypothesize that Ptpn22 positively regulates TLR-induced T1 IFNs production and IFN-dependent signaling events. To determine the role of Ptpn22 in TLR signaling, we will examine gene expression and transcription factor activation in murine macrophages and dendritic cells (DCs) after TLR activation. To determine the role of Ptpn22 in T1 IFN- dependent signaling, we will examine phosphorylation of STAT1 and upregulation of costimulatory molecules (UCM) in macrophages and DCs. To determine the molecular mechanism underlying the positive regulation of TI IFN production by PTPN22, we will identify PTPN22 containing protein complexes before and after TLR activation. Aim 1.1 We will determine the role of Ptpn22 in TLR induced T1 IFNs production and IFN-dependent signaling. Aim 1.2 We will determine the molecular mechanism by which Ptpn22 regulates T1 IFNs production Specific Aim #2: Determine the role of LypW in TLR signaling and RA pathogenesis To facilitate improved mechanistic understanding of human LypW variant, we developed LypW and LypR transgenic mice on both wild-type and ptpn22-/- backgrounds. We will determine the functional differences between LypW, LypR, and Pep in TLR signaling and T1 IFN-dependent signaling events using similar strategies as described in Aim 1 in our transgenic mice. We will also investigate the role of LypW in the pathogenesis of rheumatoid arthritis by using K/BxN TCR transgenic mouse arthritis model22. Aim 2.1 We will determine the role of LypW in TLR-induced T1 IFNs production. Aim 2.2 We will determine the role of LypW in the pathogenesis of murine RA. Specific Aim #3: Determine the function of LypW in human primary myeloid cells. Previous studies in human peripheral mononuclear cells (PBMCs) have shown that carriage of either one or two PTPN22 1858T (LypW) alleles is associated with significant reductions in antigen receptor signaling in T and B cells29,30. However, whether LypW inheritance is associated with alterations in human TLR or IFN signaling is unknown. Our results in genetically altered mice suggest that LypW may exhibit altered protein- protein interactions and functions in TLR signaling. Specifically, we hypothesize that LypW expression results in a hyperresponsive TRAF3//TBK1/IRF3 signaling cascade. We will compare gene expression and surface phenotype after TLR ligands stimulation in human PBMCs from LypW carriers and non-carriers. We will also determine the role of LypW in host defense to viruses including Epstein-Barr virus. Aim 3.1 We will determine the role of LypW in TLR-dependent and IFN-dependent signaling in LypW-bearing PBMCs. Aim 3.2 We will determine the role of LypW in anti-viral responses.